Administrative Core

SUMMARY
The Administrative Core will coordinate research, regulatory, and fiscal activities within the Center for Solutions
for ME/CFS in this second funding cycle and facilitate interactions with the ME/CFS patient and scientific
communities. It will be led by the PI, W. Ian Lipkin (Director), and Administrative Director, Diane McFadden, and
collaborate with community groups as well as new scientific partners in the UK.
We will expand our research team to include new partners and aims who bring complementary and unique
resources to the program. In Project 1, members of the ME/CFS community and two clinician-investigators
(Levine and Komaroff) who developed a smartphone app in close collaboration with Care Evolution and Solve
ME will collect data and biological samples in close temporal proximity to changes in clinical status for molecular,
microbiological, and biochemical analyses. Moreau of ICanCME will join, bringing expertise in microRNA biology
and strengthening linkage to the Canadian ME/CFS research community. In Project 2, Christopher Ponting of
the University of Edinburgh will initiate a GWAS that leverages the 25,000 ME/CFS subject DecodeME GWAS
project in the United Kingdom and further strengthens these international linkages. Solve ME (Oved Amitay) and
the ME/CFS community are critical partners in this effort. In Project 3, we will establish a collaboration with the
US Air Force Academy (Armand Balboni) in Colorado Springs to enable access to electronic medical records
and the Department of Defense Serum Repository for the first prospective population-based cohort study of
environmental exposures that may trigger or exacerbate ME/CFS.